NINDS Human Cell and Data Repository (U24)

As home of the NINDS Human Cell and Data Repository (NHCDR), RUCDR distributes iPSC and source cells to the global scientific community. In addition to cell lines funded by NINDS, the NHCDR also stores and distributes the only publicly available GMP iPSC line funded by the NIH. Since this cell line is critical to the development of future clinical therapies, a portion of the cell line is stored at an offsite emergency backup location at Lonza in Walkersville Maryland. This application is intended to support this off site storage.

Public health relevance
Project Narrative iPSC are increasingly utilized in disease modeling, drug discovery and toxicological testing and there is an emerging need for iPSC that are suitable for therapeutic applications. The NHCDR distributes the only publically available iPSC line created under good manufacturing practices (GMP), the first step in having a cell line that has potential to be used in clinical therapies. The NHCDR and RUCDR have distributed this cell line to more than 50 academic and private organizations who will use the line in their pre-clinical and clinical programs.